RFA-CK-23-001, Clinical and Applied Research Strategies for the Prevention and Control of Fungal Diseases

Project summary:
This proposal which is entitled "Defining epidemiology, diagnosis, prevention and treatment
of invasive fungal infections in the United States" is an ambitious and overarching proposal
which covers a host of issues in the clinical mycology arena. This proposal represents a series of
independent projects that will be initiated in sequential fashion throughout the course of this 5-
year award. The Mycoses Study Group (MSG) with its central unit located at UAB in the
division of infectious diseases will be administering this program. The proposal has 3 broad
specific aims which address some of the most important current public health issues and
challenges as it relates to fungal infections. In the first aim, we will develop and maintain
reliable and innovative methods of national fungal surveillance while also assessing specific risk
factors for acquiring these infections in the treatment and outcomes associated with these
disorders. The second aim will address a huge gap in the management of invasive mycoses,
specifically improving the utility and the scope of fungal diagnostics. We will explore this
through reviewing the existing utilization of fungal diagnostics but also creating a specimen
repository that is linked to specific patients with the purpose of developing new diagnostics.
Finally, we will explore specific public health interventions which may serve to mitigate the
significant impact of fungal infections both in the general population and in specific high-risk
subgroups. To accomplish these ambitious goals obviously requires significant coordination of
efforts among a broad range of investigators, clinical centers, laboratories, and the CDC. The
Mycoses Study Group is uniquely positioned to coordinate these efforts given his extensive
history of designing coordinating and implementing both clinical and epidemiologic trials in
mycology since 1978. We believe that at the completion of this award we will have moved
much closer to understanding of current epidemiology of fungal infections in the United States
will also have a much clearer picture of those who are at particularly high risk of developing
severe complications from these infections. Moreover, we believe that we will have made
significant strides towards improved deployment of existing fungal diagnostics and significant
progress towards the development of new diagnostics. Finally, we will improve outcomes
through increased public awareness and specific and strategic interventions which target
individuals at highest risk and who may realize the greatest benefit from preventative strategies.

Public health relevance
Project narrative: This proposal entitled "Defining the epidemiology, diagnosis, prevention, and treatment of invasive fungal infections in the United States" is a broad and ambitious project which seeks to enhance the overall understanding of invasive mycoses in the general population, but also in individuals who are at enhanced risk of complications from these infections. The project will be coordinated through the MSG Central Unit located at the University of Alabama at Birmingham, and will involve the participation of a large number of clinical and laboratory investigators from centers across the country who share the specific interest in clinical mycology. The overarching goal of this project is to reduce morbidity and mortality of invasive fungal infections through greater understanding of their epidemiology, risk factors for acquisition, and specific interventions which might lead to better overall outcomes for individuals with these complex infections.